National Resource Core

NATIONAL RESOURCE CORE: PROJECT SUMMARY
American Indian and Alaska Native (AI/AN) communities are at substantial risk of diabetes. Consequently, In
1997, Congress created the Special Diabetes Program for Indians to fund diabetes prevention and treatment
programs throughout Indian Country. This initiative led to substantial improvement in blood glucose, blood
pressure, and cholesterol levels among AI/ANs with diabetes, accompanied by significant decline in diabetes-
related end-stage renal disease. Yet the lessons from this exciting work have been slow to be learned. The
Center for American Indian and Alaska Native Diabetes Translation Research (CAIANDTR) at the University of
Colorado Anschutz Medical Campus (UC/AMC) addresses this problem by extending the knowledge, skills,
and experience of our Research Base – drawing from UC/AMC faculty and those at our 7 Satellite Centers –
that emphasizes 6 specialty areas, including cultural adaptations of intervention, health literacy, health
technologies, dissemination and implementation science, sustainability, and qualitative research methods -- to
facilitate a multidisciplinary, culturally grounded, problem-oriented translational research program of major
scientific and programmatic importance. This Core promotes the dissemination of such work and rigorously
evaluates the impact of the training, technical assistance, and consultations provided to external investigators,
programs, and institutional partners in the U.S. work with AI/AN communities to advance diabetes translational
research and reduce resulting disparities.